IL-13 Atopic Dermatitis and Its Relationship with the Development of Asthma

DESCRIPTION (provided by applicant): Atopic dermatitis (AD) has been proposed as the cutaneous manifestation of a systemic disorder that also gives rise to asthma and allergic rhinitis, the so-called atopic march. AD and other atopic disorders have an overlapping pathogenesis and genetic basis. In addition, AD and asthma share some common immunological features, including elevated IgE, peripheral and lesional eosinophilia, Th2 cytokine elevation, epithelial dysfunction and similar allergenic triggers. Th2 inflammation is an important component in the pathogenesis of both asthma and AD. Interleukin-13, a major Th2 cytokine, is believed to be involved in the pathogenesis of AD. However the precise molecular mechanisms underlying AD still remain elusive and the relationship between AD and asthma is poorly understood. We have recently developed an externally regulatable overexpression transgenic model system in which IL-13 is selectively expressed in the murine skin. In our preliminary studies, expression of IL-13 in the skin causes a chronic pruritic inflammatory skin disease with many characteristics closely resembling those of human atopic dermatitis. Many proinflammatory cytokines are highly upregulated, including IL-17 and TSLP, in the skin. IL-13-induced chronic dermatitis causes a systemic Th2-prone environment. Moreover, IL-13-induced dermatitis is associated with increased pulmonary inflammation, mucus metaplasia and airway hyperresponsiveness to allergen challenges, suggesting that IL-13 induced AD predisposes to an asthma phenotype. From these studies, we hypothesized that IL-13 plays an important role in the pathogenesis of atopic dermatitis and IL-13-induced atopic dermatitis leads to the development of asthma. In this application, we propose to: (1) Further characterize the skin-specific IL-13 transgenic model of AD and define the downstream cellular, molecular, and immunological mechanisms of IL-13-induced AD; (2) Determine if IL-13-induced AD leads to increased susceptibility to the development of allergic phenotype in the lung and the immunological mechanisms that underlie the progression from AD to asthma; and (3) Define the role of TSLP in IL-13 induced AD and in increased susceptibility to the development of allergic response to allergens in the lung. These studies will provide better understanding of the role of IL-13 in the pathogenesis of AD and its relationship with the development of asthma and the cellular and molecular mechanisms underlying these related disorders.

Public health relevance
PUBLIC HEALTH RELEVANCE Narrative: Atopic dermatitis and asthma are closely related allergic disorders that share many immunological features, including Th2-dominated immunity during the course of the disease. We have developed a mouse model of atopic dermatitis in which IL-13 is targeted to the skin and expression of this major Th2 cytokine causes both atopic dermatitis and asthma-like phenotypes in mice. We propose in this project to utilize this model of "atopic march" to explore the molecular, cellular, and immunological mechanisms that underlie the pathogenesis of atopic dermatitis and its relationship with the development of asthma. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Atopic dermatitis (AD) has been proposed as the cutaneous precursor of a systemic evolving disorder termed the "atopic march", which progresses from AD to asthma and allergic rhinitis 1. This is supported by recent longitudinal studies on patients with AD and by studies of animal models of AD in which epicutaneous sensitization with allergen predisposes to airway hyperreactivity 2. Increased Th2 cells and Th2 cytokines, such as interleukin-13 (IL-13), are present in the lesional and unaffected skin of AD patients. Asthma is a chronic inflammatory disorder of the airways. The symptoms of asthma are closely associated with increased Th2 cytokines in the airways, such as IL-4, IL-5, and IL-13 3. A substantial body of evidence points to a singular role for IL-13 in the regulation of the allergic diathesis. The importance of IL-13 in allergic disorders in humans is supported by consistent associations between tissue IL-13 levels and genetic variants in the IL-13 gene with asthma and related traits 4-7. However, important questions about the role of IL-13 in the initiation of the pathology of atopic dermatitis and subsequent development of asthma remain poorly understood. We have recently developed inducible transgenic models in which specific promoters were used to direct the expression of IL-13 in the skin. As shown in our preliminary data, overexpression of IL-13 in the skin caused a chronic pruritic inflammatory disease with many features resembling those of human AD. In addition, IL-13- induced chronic inflammatory dermatitis results in a systemic Th2-prone environment. Furthermore, the initiation and perpetuation of this IL-13-induced chronic dermatitis leads to increased pulmonary allergic inflammation, mucus metaplasia and airway hyperresponsiveness (AHR) upon allergen challenge. Thus these mice provide us with a unique and controllable mouse model of AD and the "atopic march". From these studies, we hypothesize that: IL-13 expression in the skin is sufficient to initiate atopic dermatitis, which leads to increased susceptibility to the development of asthma. To test these hypotheses we propose the following three specific aims: Aim 1: Test the hypothesis that dermal IL-13 expression is sufficient to cause a skin condition in mice resembling human AD; determine the inducibility and reversibility of the skin phenotype; and define the cellular, molecular, and immunological mechanisms of IL-13-induced AD To further characterize the skin phenotype of our newly developed keratinocyte-derived promoter (K5) controlled IL-13 transgenic mice (K5-tTA-IL-13), we propose to: a. Define the pathology and the kinetics of the development of AD, including before clinical onset of AD, clinical AD phase, and the reversibility of the skin disease. The latter will allow us to test if the effects of IL-13 on the skin can be halted (and the impact on lung inflammation and AHR as in Aim 2). b. Define the cellular, molecular, and immunologic mechanisms by which IL-13 induces the skin disorder. This includes: " Determine the downstream genes regulated by IL-13, including cytokines, chemokines, and mediators, in the process of skin inflammation. " Determine the role of interleukin 17 (IL-17), a proinflammatory cytokine that is seen upregulated in the skin of IL-13 transgenic mice. We will breed K5-tTA-IL-13 mice with IL-17 KO mice (in collaboration with Dr. Chen Dong from MD Anderson Cancer Center) and analyze the phenotype. " Determine the role of mast cells by breeding the IL-13 transgenic mice on to the Kitw-sh/w-sh genetic background and analyzing the phenotype. Aim 2: Test the hypothesis that IL-13-induced AD leads to increased susceptibility to the development of allergic phenotype in the lung and determine the immunological mechanisms that underlie the progression from AD to asthma a. Define the effects of AD on pulmonary responses (lung inflammation and AHR) in the absence of allergen stimulation before clinical onset of AD, during AD and when AD is stabilized after the IL-13 transgene is turned off. b. Define the effects of AD on pulmonary responses before clinical onset of AD and during AD using conventional protocol of intraperitoneal (i.p.) allergen sensitization followed by a single dose of intranasal (i.n.) allergen challenge. c. Define the effects of AD on pulmonary responses before clinical onset of AD and during AD using epicutaneous (EC) allergen sensitization followed by inhaled allergen challenge. d. Determine whether EC sensitization with one set of allergens (Ova) would prime for pulmonary responses to a different set of allergens (HDM) before clinical onset of AD and during AD. e. Characterize the systemic immunity, including cytokines and immunoglobulins and their correlation with the onset and progression of IL-13 induced AD and the development of pulmonary phenotype. Aim 3. Test the hypothesis that IL-13 stimulates TSLP expression in the skin and TSLP plays a critical role in mediating IL-13 induced AD and in increased susceptibility to the development of allergic responses to allergens in the lung TSLP has been shown to initiate asthma and atopic dermatitis through a Th2 immune response. We found highly increased expression of TSLP at the site of IL-13-induced dermatitis. We will perform experiments to test whether IL-13-induced AD and increased susceptibility to asthma is TSLP dependent and the influence of TSLP on its target cell types. a. Determine the expression of TSLP in the skin and lung of K5-tTA-IL-13 transgenic mice. b. Determine whether IL-13 can directly or indirectly stimulate TSLP expression in keratinocytes in vitro and the mechanisms involved. c. Determine the role of TSLP in IL-13-induced AD and the development of asthma by breeding the IL-13 transgenic mice to the TSLP receptor knockout background (in collaboration with Dr. Warren Leonard from NIH) and by using TSLP neutralizing antibody. d. Evaluate the activation and functional status of antigen presenting cells (APC) and T cells in lymphoid tissues and in peripheral blood that are involved in the development of enhanced pulmonary responses and test whether these are TSLP dependent.